Novel strategies to accelerate repair of drug-induced hepatotoxicity

Acute liver injury caused by overdose of the pain medication acetaminophen (APAP) is a leading cause of acute liver injury in the United States. In many cases, a failure of liver repair causes acute liver injury to persist and this can progress to acute liver failure (ALF). Acute liver injury and ALF have a poor prognosis and little therapeutic options beyond intensive care. Over the past decade, several studies have highlighted how changes in the hemostatic system are connected to the progression of ALF. For example, an unbalance in the platelet adhesive protein von Willebrand Factor (VWF) and its primary regulatory enzyme ADAMTS13 have been identified as unique indicators of increased risk for liver transplant and death in patients with ALF. Our published studies indicate that VWF inhibits repair of the APAP-injured liver. Strong preliminary results using mice with deficiencies in VWF or ADAMTS13, leading-edge VWF-targeted therapeutics, and human ALF samples suggest that VWF inhibits the resolution of APAP-induced liver injury. Based on our published and preliminary studies, our central hypothesis is that hepatic VWF deposition inhibits the resolution of APAP-induced liver injury through formation of intrahepatic VWF-platelet microthrombi. Our approach includes genetically-modified mice, VWF-targeted molecules in clinical development, novel molecules designed to hold VWF in a resting state, and novel VWF-targeted thrombolytic drugs. These studies are closely aligned with creative analyses in which we seek to uncover VWF-focused biomarkers as novel biomarkers of liver repair and outcome in samples from a large, well-characterized cohort provided by the ALF Study Group. Our investigative team at Michigan State University has expertise in hemostasis and liver disease, VWF and thrombolysis, and partner with highly collaborative physician-scientists in the ALF Study Group, maximizing the impact of our studies and potential for translation. Our proposed studies will determine the role of ADAMTS13 and VWF multimer size in APAP-induced liver injury and repair (Aim 1), determine the mechanisms linking VWF to inhibition liver repair after APAP challenge (Aim 2), and identify strategies to accelerate degradation of pathologic VWF deposits to enhance repair of the APAP-injured liver (Aim 3). The expected outcome of these Specific Aims is the discovery of novel mechanisms whereby VWF inhibits repair of the injured liver. This outcome would make a significant impact on the field because it would deliver novel mechanistic details for clinical associations between VWF and poor outcome in acute liver injury. The proposed studies are transformative and anticipated to deliver clinically applicable strategies to accelerate repair of the liver, owing to a strong combination of experimental and translational science backed by clinical and basic research expertise.

Public health relevance
PROJECT NARRATIVE Hepatotoxicity caused by overdose of the analgesic drug acetaminophen is a leading cause of acute liver failure (ALF), a serious condition with poor prognosis and few therapeutic options beyond intensive care. High levels of the platelet adhesive protein von Willebrand Factor (VWF) have been linked to an increased risk of liver transplant and death in ALF patients, and experimental evidence suggests that VWF inhibits repair of the acetaminophen-injured liver. The primary goals of this research program are to uncover the mechanisms whereby VWF inhibits resolution of acetaminophen-induced liver injury and to provide proof-of-concept that VWF is a viable target to accelerate recovery after acute liver injury.